NT-I7, a novel long-acting interleukin-7, in combination with anti-PD-1 checkpoint blockade for the treatment of glioablastoma

PROJECT SUMMARY
Patients with glioblastoma (GBM) are routinely treated with radiation (RT), temozolomide (TMZ), and
glucocorticoids. However, these treatments often result in long lasting treatment-related lymphopenia
(TRL) that is associated with shorter survival. In addition, lymphopenia is associated with
unresponsiveness to checkpoint inhibitors. Here, we explore a novel approach to mitigate TRL in order
to enhance response to immunotherapy and improve survival in GBM. Interleukin 7 (IL-7) is a
hematopoietic growth factor and homeostatic cytokine that preferentially supports the growth and survival
of the B and T lymphocytes. NT-I7 is a novel long-acting form of recombinant human IL-7 fused with
hybrid Fc. We recently reported that NT-I7 significantly prolonged survival in glioma murine models
through increasing cytotoxic CD8 T cells and decreasing regulatory T cells in the tumor. The survival
advantage from NT-I7 is CD8 dependent in our model. Additionally, we conducted a first in-human phase
I/II clinical trial to evaluate the safety and effect of NT-I7 on absolute lymphocyte counts (ALC) in patients
with gliomas following standard RT and TMZ therapy. We found that NT-I7 is well tolerated and
significantly increased ALC. Immunophenotyping of peripheral blood suggested predominately CD8
expansion following NT-I7 administration. In addition, preliminary data from an immune resistant CT2A
murine glioma model demonstrated that combination of NT-I7 with anti-PD-1 blockade increased survival.
Thus, we have developed a new phase II study with a safety run-in cohort evaluating the safety and
efficacy of neoadjuvant and adjuvant NT-I7 plus pembrolizumab in patients with recurrent GBM. Here we
are requesting funding for obtaining and processing specimens and for conducting proposed correlative
studies associated with this trial as outlined in Aim 1. In addition, we will be conducting preclinical studies
to dissect the mechanisms of NT-I7 immunotherapeutic effect. We hypothesize that NT-I7 can enhance
immune response through antigen specific priming CD8 response and improve anti-tumor efficacy of
checkpoint blockade in GBM. In Aim 1, we will collect pre- and post-treatment tumor tissues and
peripheral blood to conduct comprehensive immuno-profiling using state-of-the-art CyTOF and Hyperion
Imaging Mass Cytometry. Additionally, we will assess CD8 T cell infiltration within the CNS and evaluate
the predictive performance of peripheral CD4 and CD8 Tscm as a biomarker of therapeutic efficacy. In
Aim 2, we will dissect the mechanisms of NT-I7 on enhancing CD8 T cell trafficking and infiltration into
the CNS in glioma murine models. Our group has generated novel transgenic mice that enable conditional
silencing of the MHC class I molecules, H-2Kb on specific cell types. We will employ these transgenic
mice to define the specific antigen presenting cell subsets (macrophages, microglia, and dendritic cells)
contribute to the generation of distinct brain infiltrating CD8 T cell responses with NT-I7 treatment.

Public health relevance
NARRATIVE This proposal aims at advancing a novel long-acting interleukin-7 agnoist, NT-I7, that mitigates systemic lymphopenia in patients with glioblastoma and enhances cytotoxic CD8 T lymphocytes infiltration into the tumor in glioma murine models. We will perform extensive immune profiling on pre- and post-treatment tumor tissues and blood samples from patients enrolled in our new clinical trial testing the combination of NT-I7 and pembrolizumab, an anti-PD-1 antibody, to understand the local and systemic immune impact of NT-I7 in patients with recurrent glioblastoma. Furthermore, we will employ novel MHC class I molecule conditional knockout mice to dissect the role of antigen presentation and impact of CNS infiltrating CD8 T cell responses with NT-I7 administration.